Improving diabetes prediction using clinical factors, proteomic biomarkers, and polygenic risk scores

PROJECT SUMMARY/ABSTRACT
Mary Rooney, PhD, MPH is a junior faculty member at the Johns Hopkins Bloomberg School of Public Health
Department of Epidemiology at the level of Assistant Research Professor. She seeks a K01 Mentored
Research Scientist Development Award to become an independent research scientist in the area of diabetes
prediction and -omics. This research proposal details a 5-year plan to refine current prediabetes definitions to
better predict who will develop diabetes and its complications using clinical factors, novel proteomic
biomarkers, and polygenic risk scores. The specific aims of this research are to: 1) harmonize datasets and
pool participant-level data from 13 epidemiologic cohorts; 2) refine prediabetes definitions by integrating
information on clinical factors, novel proteomic biomarkers, and genetic susceptibility; and 3) quantify the
associations of clinical, proteomic, and genetic risk stratification groups with risk of diabetes complications.
Short-term career goals include advanced training in multiple -omics research, leading a meta-analysis within a
consortium and the development and validation of diabetes risk prediction equations. The proposed mentored
research and career development activities fill training gaps needed to facilitate Dr. Rooney’s transition into a
successful independent researcher. A more precise approach to diabetes risk stratification can inform clinical
and public health strategies for the screening and primary prevention of diabetes and its complications.

Public health relevance
PROJECT NARRATIVE Current definitions for prediabetes inadequately identify adults with high diabetes risk. The goal of this application is to refine risk assessment in prediabetes using clinical factors, novel proteomic biomarkers, and polygenic risk scores to better predict who will develop diabetes and its complications .